Developing PBPK-model based mechanistic IVIVC for PLGA implants

There is an immediate need to understand the critical formulation parameters that may affect product
performance in vitro and in vivo, with a goal of developing IVIVCs for long-acting injectables. In this proposal,
we will develop IVIVCs for a long-acting PLGA-based solid implant using a physiologically based
pharmacokinetic (PBPK) modeling approach. PBPK modeling “provides a unique opportunity to understand how
the physicochemical properties of drug molecules/polymer, implant specific properties, critical formulation
attributes, and physiology, among other things, influence the in vivo release mechanisms of LAI drug products
and their disposition characteristics. Successful execution of the project will entail (1) developing a bio-predictive
in-vitro release testing method and determining how critical formulation and physicochemical properties impact
the in-vitro release of PLGA-based buprenorphine implants; and (2) using a bottom-up PBPK approach to build
IVIVCs that predict in-vivo PK profiles of PLGA-based buprenorphine implants from in-vitro data.

Public health relevance
A PBPK model-based mechanistic IVIVCs will be built for PLGA-based long-acting solid implants. The use of PBPK modeling provides a unique opportunity to understand how the critical quality attributes of the implant affect in vivo release of implants. The modeling can also help define ‘safe space’ for critical formulation attributes, explain the source of PK variability, and extrapolate prediction to human subjects.